BEHAVIORAL ROLE OF SYNAPTIC MODULATION

Description of Application for an ADAMHA Scientist Development Award. I am committed to a scientific career of research into the neural basis and cellular mechanisms of behavior and its plasticity. I am aware, however, that I do not yet possess the broad-ranging technical expertise that would allow me to independently undertake the kind of integrated, multidisciplinary investigation necessary to understand these complex questions. By permitting me to work with and learn from a technically expert Preceptor already active in the field, award of the SDA will allow me to begin such a project nevertheless. I have chosen to work with Dr. K. Weiss, whose use of a relatively simple invertebrate model system, the marine snail Aplysia, has enabled him to make considerable progress toward revealing the neural and cellular mechanisms of behavioral plasticity (specifically, plasticity of the animal's feeding behavior) that arises from changes in motivational state (food-induced arousal and satiation). this work, focusing on a representative feeding muscle and its innervating motorneurons, has revealed that, on the cellular level, much of this plasticity is due to release, under the appropriate behavioral conditions, of modulatory neuropeptide cotransmitters from the same motorneurons whose primary transmitters mediate the behavior. Preliminary evidence indicates that one family of these peptides, the buccalins, act at autoreceptors on the very same presynaptic terminals from which they were released to cause feedback inhibition of release of the neurons' primary transmitter, acetylcholine, but not of themselves or the other peptide cotransmitters. The general hypothesis that I propose to test in this system is that a major function of such differential presynaptic autoinhibition is to match to behavioral demands the ratio of transmitters and cotransmitters released from the same neuron and thus optimize the behavioral output of the organism during changes in its motivational state. Specifically, I shall determine the patterns of activity of the motorneurons in freely feeding animals, and then similarly stimulate the motorneurons in vitro to determine if with these behaviorally relevant stimulation parameters the buccalins are actually released. To determine whether the buccalins are released in sufficient amounts to produce behavioral effects, antibodies and receptor blockers will be used to interfere with their actions. Experiments to confirm the presynaptic site and the differential nature of the inhibition, and studies of the intracellular mechanisms of buccalin action will complete the project. Apart from its scientific rationale, I propose this logically developing sequence of research so that it will naturally involve my technical training as it becomes necessary to the research. In this way, my wish to answer the scientific questions will become the motivation and goal of the technical training, and my ability to answer them successfully will be the validation of its adequacy. By the end of this project I hope to have become expert in the great variety of approaches and techniques required to study the neural basis of behavior, memory and learning, with relevance to issues of human mental health and illness.